The RaDIANT Health Systems Intervention for Improving Access to Kidney Transplantation

For most patients with end-stage kidney failure, kidney transplantation confers longer survival, better quality of life, and lower cost, relative to dialysis. Despite these benefits, too few patients make it through the complex transplant evaluation process. Some patients, including individuals residing in certain geographic regions and those with lower socioeconomic status, experience substantially lower access to each transplant step, including referral, start and completion of the transplant evaluation, and placement on the waiting list. In 2010, with the explicit goal of improving access to transplant in the US Southeastern region that includes Georgia, North Carolina, and South Carolina, we created the Southeastern Kidney Transplant Coalition, a collaborative of transplant community members, including patients, caregivers, medical professionals, patient advocacy groups, and health system administrators that encompasses all 11 transplant centers in these states and large dialysis organizations serving a population of >50,000 patients with kidney failure. Since its inception, our Coalition has conducted several pragmatic interventions of educational and quality improvement activities at the dialysis facility, provider, and patient levels, finding increased rates of referral and evaluation start. Unfortunately, health system barriers persist after referral and education: more than half of patients referred did not start the transplant evaluation, and 65% of those referred were never waitlisted. Prior interventions were limited to interventions at the patient- and dialysis facility-levels and did not address the structural barriers embedded in dialysis and transplant center policies and practices, which impede patient progression in the complex process to get a transplant. In surveys of health system staff and a scoping review, we identified persistent health system barriers to transplant access, including referral closure policies, fundraising requirements, scheduling logistics, and inadequate communication among providers across health systems. Leveraging proven interventions from our research and using a community-based participatory research approach, we will adapt and enhance the sustainability of the RaDIANT interventions targeting structural barriers to evaluation start at the health system level (Aim 1). The developed RaDIANT Health Systems intervention, which includes transplant center audit-and-feedback or “benchmarking” reports related to referral and evaluation, and facility-specific quality improvement activities focused on enhancing communication, streamlining referral follow-up, and improving patient engagement through more coordinated practices between dialysis and transplant centers, will be evaluated through a hybrid type 1 effectiveness-implementation quasi-experimental study among 4 Southeastern transplant centers and ~800 dialysis facilities in GA, NC, and SC with a goal of improving transplant access (Aim 2). Finally, we will conduct a process evaluation among the participating health systems to assess the acceptability, usability, implementation, and sustainability of interventions (Aim 3). If successful, interventions could be adapted and scaled nationally, where our health system partners are committed to improving access to kidney transplantation for individuals whose access has been obstructed by health system-level barriers.

Public health relevance
Prior successful interventions to address barriers in access to kidney transplantation for groups who experience lower access along the transplant pathway have been focused on provider- and patient-level interventions, and yet, substantial health system barriers have hindered access to kidney transplantation for many patients. Leveraging proven educational and quality improvement interventions, this study will target multiple health systems– dialysis facilities and transplant centers – as well as clinical staff and patients in the Southeastern United States by implementing the RaDIANT Health Systems intervention, which includes transplant center benchmarking reports and center-selected strategies to improve coordination, communication and patient engagement for individuals with end-stage kidney failure seeking a kidney transplant. If successful, interventions could be adapted and scaled nationally, where our health system partners are committed to improving early transplant access. References System USRD. 2019 USRDS Annual Data Report: Epidemiology of kidney disease in the United States. 2019. Tonelli M, Wiebe N, Knoll G, et al. Systematic review: kidney transplantation compared with dialysis in clinically relevant outcomes. Am J Transplant. Oct 2011;11(10):2093-109. doi:10.1111/j.1600-6143.2011.03686.x Patzer RE, Pastan SO. Measuring the Disparity Gap: Quality Improvement to Eliminate Health Disparities in Kidney Transplantation. American Journal of Transplantation. 2013;13(2):247-248. doi:10.1111/ajt.12060 Harding JL, Perez A, Patzer RE. Nonmedical barriers to early steps in kidney transplantation among underrepresented groups in the United States. Curr Opin Organ Transplant. Oct 1 2021;26(5):501-507. doi:10.1097/mot.0000000000000903 Axelrod DA, Dzebisashvili N, Schnitzler MA, et al. The Interplay of Socioeconomic Status, Distance to Center, and Interdonor Service Area Travel on Kidney Transplant Access and Outcomes. Clinical Journal of the American Society of Nephrology. 2010;5(12):2276-2288. doi:10.2215/cjn.04940610 Zhou S, Massie AB, Luo X, et al. Geographic disparity in kidney transplantation under KAS. Am J Transplant. 2018;18(6)doi:10.1111/ajt.14622 Davis AE, Mehrotra S, McElroy LM, et al. The Extent and Predictors of Waiting Time Geographic Disparity in Kidney Transplantation in the United States. Transplantation. 2014;97(10):1049-1057. doi:10.1097/01.tp.0000438623.89310.dc Patzer RE, L P, J K, Pastan SO. Dialysis facility and network factors associated with low kidney transplantation rates among United States dialysis facilities. Am J Transplant. 2014;14(7)doi:10.1111/ajt.12749 Coalition TSKT. The Southeastern Kidney Transplant Coalition. https://sektc.org/ Patzer RE, Paul S, Plantinga L, et al. A Randomized Trial to Reduce Disparities in Referral for Transplant Evaluation. J Am Soc Nephrol. Mar 2017;28(3):935-942. doi:10.1681/asn.2016030320 Hamoda RE, Gander JC, McPherson LJ, et al. Process evaluation of the RaDIANT community study: a dialysis facility-level intervention to increase referral for kidney transplantation. BMC Nephrol. Jan 15 2018;19(1):13. doi:10.1186/s12882-017-0807-z Patzer RE, Buford J, Urbanski M, et al. Reducing Disparities in Access to Kidney Transplantation Regional Study: A Randomized Trial in the Southeastern United States. Clinical Journal of the American Society of Nephrology. 2025;20(2):256-266. doi:10.2215/cjn.0000000586 Patzer RE, McPherson L, Wang Z, et al. Dialysis facility referral and start of evaluation for kidney transplantation among patients treated with dialysis in the Southeastern United States. Am J Transplant. Jan 25 2020;doi:10.1111/ajt.15791 Browne T, McPherson L, Retzloff S, et al. Improving Access to Kidney Transplantation: Perspectives From Dialysis and Transplant Staff in the Southeastern United States. Kidney Medicine. 2021;3(5)doi:10.1016/j.xkme.2021.04.017 Minkler M, Wallerstein N. Community-Based Participatory Research for Health: From Process to Outcomes. Wiley; 2011. Eldredge LKB, Markham CM, Ruiter RAC, Fernández ME, Kok G, Parcel GS. Planning Health Promotion Programs: An Intervention Mapping Approach. Wiley; 2016. Weiner BJ. A theory of organizational readiness for change. Implementation Science. 2009;4(1):67. doi:10.1186/1748-5908-4-67 Krueger RA, Casey MA. Focus Groups: A Practical Guide for Applied Research. SAGE Publications; 2014. Glasgow RE, Harden SM, Gaglio B, et al. RE-AIM Planning and Evaluation Framework: Adapting to New Science and Practice With a 20-Year Review. Front Public Health. 2019;7:64. doi:10.3389/fpubh.2019.00064 Glasgow RE, Vogt TM, Boles SM. Evaluating the public health impact of health promotion interventions: the RE- AIM framework. Am J Public Health. Sep 1999;89(9):1322-7. doi:10.2105/ajph.89.9.1322 Kwan BM, McGinnes HL, Ory MG, Estabrooks PA, Waxmonsky JA, Glasgow RE. RE-AIM in the Real World: Use of the RE-AIM Framework for Program Planning and Evaluation in Clinical and Community Settings. Front Public Health. 2019;7:345. doi:10.3389/fpubh.2019.00345 Ashby VB, Kalbfleisch JD, Wolfe RA, Lin MJ, Port FK, Leichtman AB. Geographic variability in access to primary kidney transplantation in the United States, 1996-2005. Am J Transplant. 2007;7(5 Pt 2):1412-23. doi:10.1111/j.1600- 6143.2007.01785.x